Simian Collective Conference

PROJECT SUMMARY
This application is a request for funds to support a conference titled the ‘Simian Collective’ (SimCo) that highlights
nonhuman primate neuroscience research in the United States and its unique role in providing translational
models of human neurological, neuropsychiatric diseases and disorders, and models of healthy and impaired
aging. SimCo seeks to build a crucial community effort to address key challenges facing the field of nonhuman
primate neuroscience in the 21st Century. The conference is strategically organized to stress that maximizing
the impact of nonhuman primate neuroscience research in the modern era necessitates complementary goals
of Science, Ethics, Education and Advocacy. Owing to the shared functional organization of the primate brain,
our simian cousins are uniquely powerful models from which we can learn many facets of human brain function
in both health and disease. This cutting-edge research must continue to grow and receive renewed investments
to prosper. The SimCo meeting will also emphasize that the phylogenetic advantages of using a primate model,
which shares many unique neural and cognitive characteristics with humans, for investigative research must
also be balanced by the crucial neuroethical considerations that inevitably emerge because of these similarities.
Furthermore, the Simian Collective will also emphasize the responsibility of the members of the field to educate
our scientific colleagues and the public about the unique importance of nonhuman primate research and to
advocate for its significance. The program of the meeting emphasizes the complementary relationship between
these core tenets and seeks to build a community initiative to promote and ensure nonhuman primate
neuroscience research in the coming years. The past three conferences were extraordinarily successful with
increasing attendance, year over year. SimCo 2024 had ~250 attendees across all levels – technical staff,
students, post-doctoral fellows, and assistant, associate and full professors. We anticipate that this community
will continue to grow, attract new talent, and remain a vibrant contributor to neuroscience research.

Public health relevance
PROJECT NARRATIVE The principal goal of the Simian Collective is to showcase the significance of research with nonhuman primates in neuroscience, including the unique significance of these species as translational models of human neurological and neuropsychiatric diseases, disorders, and healthy and impaired aging. The meeting is organized to emphasize that realizing the maximal impact of nonhuman primate models in the 21st Century necessitates complementing cutting-edge research with neuroethical considerations, as well as educating our young investigators and the broader scientific and general communities about the importance of nonhuman primate neuroscience research. This meeting will provide an important forum to build the community involvement needed to take these critical steps in the next chapter of the field and to train the next generation of nonhuman primate neuroscientists.